Multilevel analysis of the bidirectional effects of cognition and psychopathology over time

Project Summary/Abstract
Mental health disorders are associated with a myriad of negative health outcomes, including a reduced life
expectancy. Recent work has begun to investigate factors that contribute to the increased mortality rate among
those with psychopathology. Emerging data implicate a link between psychopathology and the aging process
(e.g., premature cognitive decline). These findings are in line with the psychological scar theory, which posits
that psychopathology degrades cognitive abilities over time due to behavioral and emotional alterations that
can disrupt the neural correlates of cognition. At the same time, cognitive vulnerability theory suggests that a
reduced cognitive capacity may be a risk factor for the emergence of psychopathology by compromising
effective, yet cognitively demanding, coping strategies. It is thought that these cognitive vulnerabilities are also
instantiated at the neurobiological level, but relatively little work has examined this model using neural
indicators of cognition. The two competing theoretical models suggest that reduced cognitive functions may be
both a risk factor and consequence of psychopathology. However, relatively few studies have examined
whether there is a bidirectional relationship between psychopathology and cognition that exacerbates
psychological and cognitive change in middle adulthood. Investigating these hypothesized causal pathways in
midlife has the potential to identify early risk markers of cognitive decline and future psychopathology prior to
the onset of neurodegeneration. The objective of this application is to investigate the bidirectional effects of
psychopathological and cognitive processes over time in midlife. The proposed research will reassess 100
community adults across a spectrum of psychological severity who previously completed a large multi-method
study using measures of cognitive functioning and psychopathology symptomatology. Participants will be
reassessed at least 12 months after the previously collected baseline assessment and then again, every 6
months for a year (4 total assessments spanning at least 2 years). I hypothesize baseline psychopathology
severity will show a negative relationship with cognitive functions over time consistent with the psychological
scar theory (Aim 1). In addition, I expect baseline cognitive functions measured behaviorally and neurally to
show a negative relationship with psychopathology symptoms over time consistent with the cognitive
vulnerability theory (Aim 2). Finally, I anticipate bidirectional effects, such that decrements in cognitive
functions will predict worsening of psychopathology symptoms, and worsening psychopathology symptoms are
expected to predict declines in cognitive functions over time (Aim 3). Investigation of these aims will provide
training opportunities in three critical areas: i) the conceptualization of bidirectional models of psychopathology
and cognition over time, ii) the application of advanced data analysis techniques to longitudinal data, and iii)
the enhancement of knowledge on best practices in research reproducibility, rigor, and transparency.

Public health relevance
Project Narrative Although research has identified a link between psychopathology and cognitive decline, as well as the inverse causal effect, (i.e., degradation of biological and cognitive systems increasing risk for new or worsening psychopathology), investigation of a bidirectional relationship between psychopathology and cognition remains largely unstudied. The objective of this application is to investigate the bidirectional effects of psychological and cognitive processes over time in midlife to identify potential early signs of cognitive decline prior to the onset of neurodegeneration, which may in turn, reduce the likelihood of new or worsening psychopathology. The proposed training and research plans will develop the applicant’s program of research on the longitudinal interplay between psychopathology and cognition.